Preparing for Blood-Based Alzheimer’s Disease Biomarker Testing in Diverse Populations: Development of a Decision-Support Tool for Primary Care

PROJECT SUMMARY/ABSTRACT
This career development proposal is designed to provide Fred Ketchum, MD, PhD, with the necessary
training to become an independent clinician-scientist developing interventions to improve decision-
making and communication about preclinical biomarker testing that are inclusive to the needs of diverse
patients with Alzheimer’s Disease and Related Dementias (ADRD). Dr. Ketchum will build upon his
existing skills in qualitative research and medical communication to acquire additional skills in 1) user-
centered design and implementation based on healthcare systems engineering approaches; 2) design
and conduct of clinical trials of behavioral interventions with racially and ethnically diverse populations;
3) training in decision sciences. As an early-career researcher at an institution with an extensive
infrastructure to support early-stage investigators and committed expert mentors, Dr. Ketchum is in an
ideal environment to complete the proposed research and training.
This proposal seeks to develop and pilot test an intervention to support decision-making about blood
biomarker testing in primary care settings. Rapid advances towards blood biomarkers to screen for
preclinical Alzheimer’s Disease are a major step towards addressing the devastating consequences of
this condition by reducing diagnostic delays, broadening access for diverse populations, and ultimately
allowing disease modifying therapies to be started sooner. Blood biomarker testing is expected to be
used heavily by Primary Care Providers (PCPs), who make initial decisions about screening, diagnosis,
and referral for patients with cognitive complaints. However, decisions about testing are complex, and
there is a crucial need to support decisions among PCPs and their patients to address the gap between
the future availability of biomarkers and integration into routine diagnostic decisions by PCPs, thereby
advancing NIA’s strategic priority of developing effective interventions to address the burden of age-
related diseases like ADRD. Aim 1 seeks to characterize decision-making processes related to clinical
evaluations for cognitive complaints and identify decision-support needs among patients and PCPs.
Aim 2 will adapt a decision-support tool for blood biomarker testing for use in diagnostic evaluations of
cognitive complaints by PCPs in diverse populations through a user-centered design process. Aim 3
will test usability and acceptability of the intervention, and effects on shared decision-making. These
data will support submission of an R01 proposal at the end of this award to determine the effects of the
decision support tool on shared decision-making about blood biomarker testing in preclinical
Alzheimer’s Disease in a large national sample.

Public health relevance
PROJECT NARRATIVE The development of blood-based biomarkers to test for the earliest stages of Alzheimer’s Disease has significant potential to improve care, by allowing affordable, accessible, and non-invasive testing to identify patients at risk for cognitive impairment in primary care. Primary care providers and patients will face new challenges in deciding whether and when to use blood biomarker tests in their patients. This study seeks to understand how decisions about diagnosing cognitive complaints are made, and to use healthcare engineering approaches to design and test a communication intervention to support decisions about blood biomarker testing in primary care.